Leveraging Health System Telehealth and Informatics Infrastructure to Create a Continuum of Services for COVID-19 Screening, Testing, and Treatment: A Learning Health System Approach

PROJECT SUMMARY/ABSTRACT
The COVID-19 pandemic reached the US with little warning, and thus caught both public health and medical
care delivery systems inadequately prepared to cope with the pandemic. Effectively screening, testing and
treating the population for this dangerous virus became an unprecedented challenge for healthcare systems
which were in parallel suffering enormous economic challenges in maintaining normal patient care. Most health
systems have disaster plans, but the plans are focused on short-term events, such as mass casualties or
hurricanes. The Medical University of South Carolina (MUSC) had a well-developed and tested disaster plan
normally implemented to respond to disruptions due to hurricanes. An important facet of the plan is free Virtual
Urgent Care (VUC) visits hosted by the MUSC Center for Telehealth. Through collaboration across
multidisciplinary teams and strategic planning, four telehealth programs with corresponding informatics systems
were deployed in the initial weeks of the pandemic: VUC screening, remote patient monitoring for COVID-19
positive patients, continuous virtual monitoring to reduce workforce risk and utilization of personal protective
equipment, and the transition of outpatient care to telehealth. However, the speed, diverse needs, and high
volume of services were unprecedented and thus these changes require extensive evaluation to better prepare
for future challenges. This proposal aims to inform these choices through examining the effects of these four
telehealth programs and corresponding informatics innovations as initial responses to the COVID-19 pandemic.
Special attention will be paid to the ability of these innovations to address patient and healthcare worker safety
and the provision of high-quality care. Additionally, continued surveillance of the consequences of these
programs, including any unintentional exacerbation of healthcare disparities, will be examined along with the
steps taken to mitigate these effects and close gaps in care for socially vulnerable populations. Our Specific
Aims are to: AIM 1: Describe characteristics of programmatic interventions in screening, testing, and treatment
and how the urgent COVID-19 requirements modified the standard telehealth or health systems processes; AIM
2: Measure and compare the health systems COVID-19 adjustments with regards to: overall patient volume,
service uptake, delivery learning curves, and safety/quality indicators as they changed over time, with emphasis
on differences observed for underserved and high-risk populations; and AIM 3: Assess population health
outcomes, value, and cost from the perspectives of patients and providers with special attention to changes in
access to acute care, emerging gaps in preventive care, unintended consequences of COVID-19 responses,
differential effect on underserved and high-risk populations, and specific issues emerging in rural locations and
in broadband “digital deserts”. Study findings will provide evidence needed to transform care post-COVID to:
improve quality of care, optimize value, support changes in payment regulations, and mitigate effects of racial,
geographic, digital access, and economic disparities present in our current healthcare delivery systems.

Public health relevance
PROJECT NARRATIVE Effectively screening, testing and treating the population for COVID-19 became an unprecedented challenge for healthcare systems which also suffered tremendous economic hardships and challenges in maintaining normal patient care. These systems were forced to rapidly adjust standard care processes and deploy new patient care approaches to screen and care for COVID patients, as well as continue to provide services to individuals needing routine medical care while ensuring the safety of both patients and caregivers. Four telehealth programs were launched in the initial weeks of the COVID-19 pandemic (virtual urgent care screening, remote patient monitoring for COVID-19 positive patients, continuous virtual monitoring to reduce workforce risk and utilization of personal protective equipment, and the transition of outpatient care to telehealth) and this project will examine the effects of these four telehealth programs and their ability to address patient and healthcare worker safety while providing high-quality care with equal access.